Infectious Disease and Basic Microbiological Mechanisms

Infectious diseases and microbiology continue to be areas of pivotal importance in health care research.
Infection remains a major cause of mortality worldwide and poses serious problems of both individual and
public health concern in the United States. New pathogens have emerged, including some (COVID-19, Zika)
with catastrophic impact worldwide. Antibiotic resistance continues to occur at an alarming rate among all
classes of mammalian pathogens. Diseases once thought to be near eradication - for example, tuberculosis,
cholera, and rheumatic fever—have rebounded with renewed intensity. Currently in its 45th year, the Infectious
Disease and Basic Microbiological Mechanisms training program maintains as its primary goal the training of
scientists who have a career goal of solving medically relevant problems and who elect rigorous laboratory or
translational training in any of the Harvard adult infectious disease programs or other institutions participating
in this program. Over the past 45 years, the program has successfully trained leaders in academic medicine
and investigators who have made important contributions to the field.
In this competing renewal application, we propose an additional five years of funding. We request six
postdoctoral trainee slots per year. We will use these slots to provide support directly to selected infectious
disease physician fellows (M.D. and M.D.-Ph.D.) during mentored research, and to also provide support to
selected Ph.D. trainees in Harvard Medical School infectious disease and microbiology laboratories focused on
areas that have significant clinical relevance, so as to support the rich research training environment for
physician-scientists within these laboratories and to provide these Ph.D. trainees intensive exposure to
medically-trained clinically-active researchers. Training will include a minimum of two years of mentored
research with hands-on in-laboratory training, appropriate advanced non-degree-granting post-graduate
coursework, attendance and participation of trainees at regular meetings and seminars of direct relevance to
infectious disease and microbiology research, including an annual training program retreat, and instruction in
the preparation of competitive proposals for funding, with a particular emphasis on applications for K and other
career development awards, including foundation awards. The specific aims are as follows:
1. To acquire sufficient training in basic laboratory or translational techniques and approaches to conduct
effective cutting-edge research into relevant infectious disease problems;
2. To foster the creation of impactful scientific contributions by means of strong and longitudinal
mentorship by program faculty; and
3. To develop a primary research focus and a broad understanding of infectious diseases and
microbiology, so as to both enable novel interdisciplinary research and foster independence.

Public health relevance
The Infectious Disease and Basic Microbiological Mechanisms training program continues to train postdoctoral trainees as independent physician scientists (M.D. and M.D.-Ph.D.) and Ph.D. scientists able to recognize and answer clinically relevant questions in the fields of infectious diseases and microbiology. This training program is especially important now, as we witness the emergence of new infectious diseases and global pandemics, the continued challenges of illnesses due to antibiotic-resistant pathogens, and the development of revolutionary scientific technologies and approaches that have the potential to address these and other issues in the field.